DOSE RESPONSE RELATIONSHIPS AT LOW CARCINOGEN CONCENTRATIONS IN A FISH MODEL

This study is important because it explores the dose response relationship at very low carcinogen concentrations. A basic and relevant question in trying to extrapolate from NTP rodent studies to risk assessment for humans is whether at low doses the dose response relationship is linear. The work is being conducted at Gulf Coast Research Lab. in Ocean Springs, Mississippi under a cooperative agreement with EPA. NIEHS is to perform pathology evaluations.